Pilot Project 3: To be Developed - Intervention

Abstract: This project will test an intervention that will be based on the data collected from Pilots #1 and #2. The intervention will be conducted within the REACH for Survivorship Program, with clinical sites at VICC and MMC. This program is designed to meet the unique needs of cancer survivors and act as a bridge from acute oncology care to primary care. A pilot intervention is planned to better define the services provided, the way in which they are provided, and the impact of the Survivorship Clinic visit and information on physical or psychosocial health, lifestyle behaviors and quality of life.